The Intermountain West-Atlantic Center (InterACT) for the APS Phenotyping Consortium

Project Summary
This proposal presents the Intermountain West-Atlantic Center (InterACT), which brings together four robust
investigative sites to participate in the APS Phenotypes Consortium. InterACT proposes to use robust
statistical and machine learning methods to phenotype patients with Acute Respiratory Distress Syndrome
(ARDS), pneumonia, and sepsis in two broad proposals. In the first proposal for the entire Consortium, we will
use multiplex cytokine arrays and clinical variables in the setting of normalized treatment trajectories to
improve the accuracy of phenotyping by accounting for the role treatment plays. This method creates
phenotypes that will be confirmed, with an eye toward therapeutic implications, in emulated clinical trials. In the
second proposal for the Center specifically, we will focus our statistical methodology on new work investigating
the pattern of tissue injury and repair, with a focus on hyaluronan and soluble Receptor for Advanced Glycation
Endproducts (sRAGE) as tissue injury biomarkers and predictors of dysregulated inflammation. This work will
culminate in emulated trials of novel agents that modulate the pathologic consequences of tissue injury.
Together these highly innovative proposals promise actionable, treatment-responsive patient phenotypes for
future clinical trials.

Public health relevance
Project Narrative The Intermountain West-Atlantic Center (InterACT) brings together four technically experienced, high-enrolling sites to participate in the APS Phenotypes Consortium. InterACT will use robust statistical methods to phenotype patients with Acute Respiratory Distress Syndrome (ARDS), pneumonia, and sepsis in two broad proposals that incorporate target trial emulation to confirm phenotypes. The Consortium-wide proposal focuses on clinical data and inflammatory cytokines, while the Center-specific proposal investigates hyaluronan and tissue injury and repair pathways.